Multivalent Tick-Microbe targeted Lyme disease vaccines

TITLE
MULTIVALENT TICK-MICROBE TARGETED LYME DISEASE VACCINES
PROJECT SUMMARY/ABSTRACT
Lyme disease remains a prevalent tick-borne infection in many parts of the world. In the United States alone,
there are over 300,000 new cases occurring each year. The infection is caused by Borrelia burgdorferi sensu
lato, which is a group of atypical extracellular bacterial pathogens that survive in nature through a complex
enzootic infection cycle involving ticks (belonging to the Ixodes scapularis complex) and an array of vertebrate
hosts, most commonly wild rodents. Despite serious efforts to control the infection over the past several
decades, the disease is still emerging around the globe, largely due to the absence of effective control
measures against tick infestation, lack of human vaccines, difficulties in diagnosis, and clinical complications
associated with treatments which use currently available antimicrobials. Specifically, several months after
standard-care antibiotic therapy, a subset of patients can experience a series of persistent or relapsing
symptoms, known as chronic Lyme disease or post-treatment Lyme disease syndrome, for which further
treatment options remain unavailable. Therefore, the development of vaccines is highly warranted to
combat Lyme disease. This project pursues our goals to develop a novel vaccination campaign that
comprises selected antigens from both the Lyme disease pathogen and the tick vector, expressed from a well-
established viral vector system. The approach incorporates a set of novel vaccine targets that are expressed
on the microbial surface or towards the luminal surface of the tick gut. As highlighted in recently-published and
preliminary data, immunization with these targets generates protective immunity in mammals. We will
utilize highly efficient Rabies virus-based vaccine systems (RABV), which have broad applications as
competent vaccine platforms for many infectious diseases and display remarkable safety profiles, as
evidenced from their current use for human vaccination. The overall objective is embodied in three specific
aims: 1) construction of a battery of recombinant replication-competent, replication-deficient RABVs
and virions expressing B. burgdorferi and tick antigens, 2) characterization of vaccine constructs for
long-term immunogenicity in murine models, and 3) identification of the most effective vaccine
candidate(s) that modulate B. burgdorferi infection and generate protective immunity. We will also
perform studies for understanding the mechanisms of the humoral and cellular immune responses associated
with host protection. Overall, these studies will facilitate the design of safer, next generation vaccines to
prevent the incidence of Lyme borreliosis. Moreover, the same approach may serve as a paradigm for
combating other tick-borne infections.
!
!
!

Public health relevance
PROJECT NARRATIVE Prevention of Lyme disease remains a challenge because of a lack of human vaccines and the frequent presence of chronic symptoms after standard-care antibiotics. This project will develop next-generation Rabies-based vaccine platforms based on a novel strategy utilizing unique spirochete and tick antigens, which facilitates transmission and infectivity of Lyme disease pathogens in the mammalian host.